Development of Glycosylated Endomorphin Analogs with Low Abuse Liability for Treatment of Pain.

Project Summary/Abstract
Opioids acting at the mu opioid receptor (MOR) remain the gold standard for treatment of
moderate to severe pain relief, but their use is limited by serious side effects, particularly abuse
liability. The opioid epidemic has grown steadily in the past three decades, resulting in 137
deaths per day. In this program, we will test modifications of the core pharmacophore of an
endomorphin analog that has been shown to provide pain relief comparable to morphine while
exhibiting reduction of several side effects, including abuse liability. A series of glycosylated
analogs of endomorphin, designed to enhance blood-brain-barrier penetration, will be tested.
Preliminary tests indicate highly effective acute antinociception/pain relief for 2 of these
compounds. We will identify 3 candidate compounds and assess them for low abuse liability in
rodent models that correlate with human abuse liability. We will then test for reduction of
tolerance and respiratory depression relative to currently used opioids, and effective relief of 3
forms of pain ranging from moderate to chronic duration. Pharmacokinetic profiles will enable
planning of human studies. The goal of this project is to show proof-of-concept that these novel
endomorphin analogs can provide effective treatment of pain without rewarding properties and
other key adverse effects. Successful outcomes of this project will support development of these
compounds for clinical use as novel treatments for pain and potentially for opioid use disorder.

Public health relevance
8. Project Narrative One fifth of the US population struggles with chronic pain, but the only effective class of drugs for treatment of severe pain also drives the opioid addiction and overdose epidemic. We have synthesized a series of opioid pain killers with reduced side effects, including abuse liability. In this project, will identify and optimize related analogs, designed for improved brain delivery, for improved treatment of pain with low abuse liability, tolerance, and respiratory depression relative to currently used opioids. Successful tests will provide proof-of-concept that the novel compounds can effectively treat pain with reduced side effects and provide support for development for clinical use.